EFFECT OF CYCLOSPORINE ON VASCULAR REACTIVITY

Determine whether administration of cyclosporine alters the vascular response to vasodilators and vasoconstrictors. Determine whether administration of cyclosporine alters sympathetic activity, and determine individual variability in Cytochrome P4550 IIIA activity predicts changes in vascular reactivity.